Harnessing the Latent Potential of Radical Migration to Drive Synthetic Innovation

Project Summary/Abstract
This proposal will exploit the unique and latent features of radical-mediated migrations to underpin new synthetic
transformations designed to facilitate the discovery and manufacture of medicines. Using this approach, we aim
to make significant advances in olefin difunctionalizations and stereoselective α-functionalizations of carbonyls.
These reaction classes have enormous potential in pharmaceutical synthesis, but technical complications with
their transition-metal catalysts have restricted the products they can directly access. To address these limitations,
we will develop new conceptual platforms that promote these transformations and are compatible with
medicinally valuable motifs that have heretofore presented challenges. In the context of olefin alkyl–arylation
and amino–arylation, we have shown that a radical-migration-based design affords clear improvements over
established strategies. Using this approach, our alkyl–arylation protocol enables (1) the use of mono- to
tetrasubstituted olefins without activating or directing groups, (2) alkylation with diversifiable partners, (3) the
formation of quaternary benzylic centers, (4) the broad use of N-rich heteroaromatic groups, and (5) good
diastereocontrol. All five of these key outcomes are nearly unprecedented in metal-catalyzed alkyl–arylations of
unbiased olefins, and they result directly from the method’s radical-migration-based design. Amino–arylation
features similar advantages. Future work will comprehensively demonstrate the utility of these methods, develop
more accessible reagents, and the introduce a further suite of amino–functionalization reactions. We will also
translate this open-shell approach to the stereoselective α-functionalization of carbonyls. In this setting, we will
develop and implement simple ‘chiral chaperones’ that are well-poised to deliver aromatics and other key
functional groups to the α-position of carbonyl compounds after a radical-generation step. Since these
transformations have struggled to introduce N-rich heteroaryl groups stereoselectively – a task for which radical-
mediated migrations hold particular promise – this approach will unlock access to a broad range of stereodefined
carbonyls bearing these privileged pharmacophores, in addition to α- and β-amino acids.

Public health relevance
Project Narrative The proposed research aims to develop new synthetic methods that will improve access to critical materials for the discovery and manufacture of medicinal agents. These methods will include (a) olefin difunctionalizations to rapidly convert simple and abundant chemical feedstocks into complex skeletons and pharmacophores, and (b) stereoselective α-functionalizations of carbonyls to generate novel amino acids and medicinal products and intermediates. Owing to their “radical-mediated migration” mechanisms that have significant latent potential, these new approaches will afford clear advances in pharmaceutical synthesis by enabling reactions with improved stereocontrol and a significantly expanded range of medicinally valuable motifs they can access.